P30 Administrative Supplement for Multi-Channel Communication Campaigns for Improvements in Cancer Education and Outcomes (MICEO) in Underserved Populations

Abstract
The proposed work will extend efforts originally funded in 2023 through the P30 Administrative Supplement for
Multi-Channel Communication Campaigns for Improvements in Cancer Education and Outcomes (MICEO) in
Underserved Populations. We will continue our work through the Karmanos Cancer Institute Office of Cancer
Health Equity and Community Engagement (KCI OCHECE) and Karmanos Academy, a major initiative to
build community capacity for improving cancer prevention and control throughout the KCI catchment area.
Over the past year, Karmanos Academy has coordinated Real Talk: Breast Cancer, led by lay health advisors
(LHAs) to increase breast cancer screening awareness and mammography adherence. Each LHA is required
to reach at least 12 individuals and this approach has been successful. To date, 25 Black/African American
LHAs have completed training and four Real Talk sessions have been conducted, reaching 64 people. At
present, LHAs have scheduled 11 more sessions through October 2024 that will reach over 100 individuals. As
part of the proposed work in the new funding cycle, we will train an additional 6 Black LHAs. Further, we will
adapt the Real Talk intervention for Middle Eastern or North African (MENA) women, a population strongly
represented in the KCI catchment area, and train 2 MENA LHAs. We will also continue creation,
dissemination, and tracking of related social media post/shareables related to the Real Talk intervention and
breast cancer screening. Our 2024 specific aims are similar to our 2023 aims, with revisions in italics: Aim 1:
Adapt an existing LHA-led psychoeducational program to increase mammography adherence among Black
and Middle Eastern or North African (MENA) women in the metropolitan Detroit area in collaboration with
community stakeholders; Aim 2: Collaborate with existing KCI OCHECE community partners to enlist and
train community members as LHAs who will deliver the adapted psychoeducational program; Aim 3: Partner
with KCI’s Marketing and Business Development Department and other community-based partners to develop
and implement a social media toolkit to promote mammography adherence among Black women in the
metropolitan Detroit area. Ultimately, the proposed work will increase breast cancer knowledge and screening
among Black and MENA women in metro Detroit through strategic use of multiple communication channels.

Public health relevance
Not Applicable